NDC MEDCHEM CONSULTING LLC

The NIH is seeking executive (senior scientific)-level, industry-experienced drug discovery and development consultants with expertise in Medicinal Chemistry to provide technical guidance in the area of Medicinal Chemistry to the following programs:

• Medicinal Chemistry consulting to procure consultant services to provide technical recommendations to the NIH Blueprint Neurotherapeutics Network drug discovery and development programs.
• Other NIH neuroscience-focused drug discovery and development programs.

Public health relevance
Subject matter expert support for developing therapies for neurological disorders